Programming Metabolically Fit TILs for Immunotherapy

ABSTRACT
Advances in molecular biology and genetic engineering have led to the design and use of modified T cells
recognize tumors to achieve significant tumor control upon adoptive cell transfer (ACT) to patients. These T cells
are either transduced with tumor antigen reactive T cell receptors (TCR), or chimeric antigen receptors (CARs).
Recently, a surge in studies with neo-antigen reactive T cells or T cells recognizing novel mutated antigens has
also shown promise. While the implementation of these studies requires significant technical resources, the
appearance of antigen loss variants also leads to less effective tumor control when using effector T cells reactive
to single tumor antigen or target molecule. Thus, there is a resurgence in using tumor infiltrating lymphocytes
(TILs), which have endogenous T cells reactive to multiple tumor epitopes, for ACT. While most studies have
used the conventional approach to expand TILs using high dose IL2, some recent studies using IL15 or IL21
showed improved tumor control. Preclinical studies have also shown that different subsets of both helper CD4+
T helper (Th) cells and CD8+ T cytotoxic (Tc) cells hold promise for clinical use in ACT protocols. Importantly, T
helper cell subsets with the ability to secrete IL-17 (Th17) have been shown to possess stem cell like phenotype
that attributes to their long-term persistence and leads to improved tumor control tumors as compared to the Th1
subsets (that secrete IFNγ, IL2, TNFα). However, contrary to these observations there are reports that Tc1 cells
exhibit improved tumor control as compared to Tc17 cells. These differences in T cell subsets response to control
tumors, is compounded by the fact that in the suppressive tumor microenvironment a large fraction of these Th
or Tc subsets acquire FoxP3+ regulatory phenotype, become dysfunctional or undergo cell death leading to
tumor reversion. Thus, ex vivo programming conditions that can render a stable phenotype with reduced
‘plasticity’ and not only controls primary tumors, but also results in formation of anti-tumor memory will be of
immense importance in ACT. We have recently established that programming conditions that bring together
‘anti-tumor effector function’ of Th1 cells and ‘stemness’ of Th17 cells lead to a superior hybrid Th1/17 (and
Tc/17) cell exhibiting long-term tumor control. Thus, in the Phase I application we successfully tested the
feasibility of programming metabolically enhanced signature to TILs from melanoma and prostate cancer
patients. For the Phase II application, we hypothesize that ex vivo programming and expansion using hybrid
T1/17 (Th1/17 and Tc1/17) culture conditions will result in a robust anti-tumor control even with fewer adoptively
transferred clinical grade metabolically enhanced TILs (meTILs). Following specific aims are proposed to
establish and develop our approach for commercialization: Specific Aim 1: To generate clinical-grade hybrid
meTILs from melanoma and prostate cancer patients. Specific Aim 2: To establish if clinical grade hybrid meTILs
are superior to conventional TILs in controlling tumor growth in vivo. We believe that this proposal will help adopt
the novel ex vivo programming conditions for generating hybrid meTILs that could be used future in adoptive T-
cell immunotherapy clinical trials.

Public health relevance
NARRATIVE Adoptive transfer of T cells that can recognize tumor and cause tumor cell death is a promising approach and has gained momentum after novel anti-tumor T cells could be engineered by viral transductions of tumor reactive T cell receptor (TCR), or chimeric antigen receptors (CAR). However, many confounding factors as susceptibility to immunosuppression, or T cell’s inability to persist and undergo activation induced cell death due to chronic antigen stimulation in a tumor microenvironment remains. In this application, we propose to generate clinical grade metabolically enhanced Tumor Infiltrating Lymphoytes (meTILs) based on our published methodology in Cell Metabolism. Successful completion of this Phase II application will support this approach where targeting immunometabolism to program TILs could be used in future trials to treat cancer patients.